System genetics of immune pathways induced by Chlamydia

DESCRIPTION (provided by applicant): The study aims to serve as a proof of concept model of individualized medicine in Infectious diseases that will also advance our understanding of innate immunity and chlamydial pathogenesis. The individual differences in susceptibility to various infectious diseases have been attributed to numerous genetic polymorphisms or genetic loci. Such population based phenotype to genotype correlations do not provide information regarding the causal immune pathways or predict how a certain individual will respond to a particular infection given their whole genotype. We have previously determined that the difference in susceptibility to Chlamydia in inbred strains of mice is determined by a genetic locus containing polymorphisms in the novel p47GTPase genes and several other modifying loci that result in differential immunological phenotypes affecting various arms of the immune system. We hypothesize that these genetic loci represent key modulators of immune responses and gene transcription. The causal relationship of the components of the immune pathway will be analyzed in Aim 1 by cross examination of gene expression data, immunological phenotype of a set of recombinant inbred mice infected with Chlamydia. In Aim 2 the data will be integrated by a multiscale computational analysis of host genotype, quantitative trait loci mapping, and Bayesian network to construct a model of how a mouse with a particular genotype will respond to chlamydial infection and validated experimentally in vivo. The completion of the study is likely to reveal innate immune pathways important to Chlamydia research as well as for the p47GTPases and have broad implications. Chlamydia is the most commonly reported cause of sexually transmitted disease that impact reproductive health of women. Also, p47GTPases have recently emerged as a central innate immune component in the pathogenesis of intracellular pathogens and putatively inflammatory disorders such as Crohn's disease. PUBLIC HEALTH RELEVANCE: The study aims to serve as a proof of concept study to predict the outcome of infectious diseases based on the genetic information of the host. The information will also enhance our understanding of the immune responses to Chlamydia.

Public health relevance
Narrative The study aims to serve as a proof of concept study to predict the outcome of infectious diseases based on the genetic information of the host. The information will also enhance our understanding of the immune responses to Chlamydia.